Selective Control of Synaptically-Connected Circuit Elements by Interluminescence - Diversity Supplement: E. CRESPO

PROJECT SUMMARY/ABSTRACT The Diversity Supplement candidate will be trained in all aspects of validating Interluminescence in vivo with acute extracellular recordings and computational sophisticated electrophysiological analysis. The experimental approach will allow the candidate to assess Interluminescence with a well-defined experimental model to dissect cortical dynamics. The training experience the candidate will gain are critical for his understanding, designing, and interpretation of state-of-the-art neural data. The training plan will complement his prior extensive training in molecular and cellular neuroscience. Following this experience in applying chemogenetic and optogenetic tools in vivo, the candidate will have an exceedingly strong background for meeting his career goals. His training will have ranged from hands-on experience developing novel probes at the level of the engineered protein, to their intended use in controlling neural activity and behavior. Therefore, this training in in vivo electrophysiology will not only significantly contribute to the parent grant but will specifically provide him the experience required to dissect neocortical dynamics and come “full circle” in the tool development pipeline. The proposed training outlined in the application is ideal given the candidate’s productive track record. An established team training strategy between the two mentors will foster the candidate’s ability to independently investigate the role of synaptically-connected circuits. The proposed supplement activities will increase the parent award’s overall impact within the original scope of award while at the same time advancing the training and career development of the candidate.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because development and validation of new technologies for selective control of synaptically-connected circuit elements across the brain during behavior is an essential next step to figuring out how they work, and how they fail in disease. Such methods are not available currently, and are required to define novel brain circuits and therapeutic strategies for treating devastating neurological and psychiatric disorders, such as depression, autism, schizophrenia, memory decline, addiction, and epilepsy. The proposed research is relevant to NIH’s mission in directly addressing the call for innovating and validating novel tools to facilitate the detailed analysis of complex circuits and enable circuit manipulation (BRAIN Initiative).